Metal Mixtures, MicroRNAs and Metabolomics in Extracellular Vesicles, and Early-life Programming of Childhood Sleep Patterns: A Longitudinal Study

SUMMARY
Sleep is an essential component of children’s development. Disrupted sleep in early life may cause short-term
and lifelong cognitive, behavioral, and metabolic disorders. Prenatal and early-life exposures to neurotoxic
metals have been linked to the sleep disruption in animal models. However, human studies supporting this link
are scarce, evaluated metals individually rather than mixtures as occurs in real-life settings, and characterized
neither the susceptible developmental time windows nor the underlying molecular mechanisms. We will study
how metal exposure during pregnancy and early life affects children’s sleep and sleep disruption during
childhood and investigate the underlying molecular mechanisms. We will leverage the unique resources of the
PROGRESS birth cohort from Mexico City, known to have a high metal exposure, with biobanked blood
specimens, and objective and longitudinal actigraphy-derived sleep measures at 4–5, 6–7, 8–9, and 10–12 years
of age. In PROGRESS children, we used a breakthrough approach developed by our team to precisely quantify
the time course of metal exposures by measuring metals trapped in teeth layers that recapitulate longitudinal
weekly exposures from the second trimester of pregnancy to the first year after birth, and cumulative exposures
up until teeth shedding in childhood. To assess potential molecular mechanisms, we will build on novel evidence
implicating circulating extracellular vesicles (EVs) in sleep biology. EVs, tiny vesicles secreted by sleep relevant
cells such as the brain, suprachiasmatic nucleus, and circulatory system, are highly sensitive to metal exposures
and are a critical signaling system regulating child sleep and circadian rhythms. EVs transport microRNAs (EV-
miRNA transcriptome) and metabolites (EV-metabolome) that affect the functions of distant recipient cells and
regulate child’s sleep. However, the roles of the EV-miRNA transcriptome and metabolome in metal exposures
and children’s sleep have not been studied. The study will be enabled by a team of excellent investigators with
complementary expertise. In Aim 1, we will determine the impact of metal exposures during pregnancy, infancy
and childhood on children’s sleep and markers of circadian rhythms longitudinally over 12 years, determining
windows of susceptibility and metal mixture effects (N=600). We will then identify circadian rhythm-related EV-
miRNA transcriptome (Aim 2) or neurotransmitter EV-metabolome (Aim 3) profiles measured across two study
visits (4-5 and 6-7 years; N=550) linking metal exposures during pregnancy and early life to children’s sleep
disruption through age 12. In both Aims 2 and 3, we will apply statistical causal modeling and pathway analysis
to characterize pathways linking metal exposures, the EV-miRNA transcriptome/metabolome, and children’s
actigraphy-derived sleep metrics. We will replicate our findings in an US-based cohort (N=100). If successful,
we will discover new, underappreciated environmental causes and mechanisms of sleep disruption that will lead
to stricter metals regulations and the implementation of interventions that help millions of children and prevent
lifelong changes associated with metal-induced sleep abnormalities.

Public health relevance
PROJECT NARRATIVE Early life exposures to neurotoxic metals may disrupt children’s sleep, which may be mediated by circulating extracellular vesicles and their microRNA and metabolite cargoes. We will study the relationship between extracellular vesicle cargo and sleep disruption during the first 10–12 years of life in a well-defined birth cohort. Our focus on early-life exposures has important implications—our study may inform stricter regulations for complex metal mixtures and will help direct public health interventions to specific time windows with high plasticity, i.e., prenatal and early life, when simple interventions could have long-lasting health benefits that impact the entire life course.